Social Determinants of Health and Quality of Cancer Care in HIV-associated Cancers

Project Summary
There are over 1.1 million people with HIV (PWH) in the United States, and nearly one-half (47%) are 50 or older.
Even in the era of modern anti-retroviral therapy (ART) PWH are increasingly developing chronic co-morbid
conditions associated with aging, including a variety of HIV-associated malignancies. The incidence of and
mortality due to many HIV-associated cancers is exacerbated among PWH compared to HIV negative
individuals. The etiology driving these findings is complicated but is thought to be due to lifestyle factors (e.g.,
smoking) and to pathophysiologic processes attributable to HIV. In addition to HIV-related inflammation, poor
social determinants of health (SDoH) also contribute to higher levels of inflammation.13-15 SDoH include “the
conditions in which people are born, grow, work, and live, and the wider set of forces and systems shaping the
conditions of daily life.” SDoH have multiple domains (e.g., housing, primary care provider access,
transportation, food security, medication affordability, substance use treatment, access to mental healthcare). In
addition to these “conventional” domains, another key domain for socially minoritized populations is stigma as a
fundamental SDoH. Indeed, systematic minoritization of socially stigmatized groups overarchingly shapes
outcomes in other SDoH domains in these populations. These effects are often amplified among multiply
minoritized populations. HIV disproportionately affects the health of many multiply minoritized groups, such as
Black and Hispanic sexual minority men, transgender women of color, and Black cisgender women, among
others. Studies indicate these multiply minoritized PWH populations are also often most likely to be impacted by
HIV-associated cancers. These studies have largely focused on behavioral and/or clinical risk factors for
malignancies without adequately addressing SDoH. Studies investigating how SDoH associate with
disparities in the screening, diagnosis, treatment and outcomes of HIV-related malignancies among
diverse – and especially multiply minoritized – PWH are therefore urgently needed. Our Chicago-based
team thus proposes to accomplish the following Specific Aims: Specific Aim 1: Develop harmonized electronic
medical record (EMR) algorithms to identify SDoH, demographic variables, and HIV care cascade outcomes as
well as screening, diagnosis, and morbidity/mortality outcomes of HIV-associated malignancies of diverse PWH
at UC and NM. Specific Aim 2: Investigate associations between SDoH and the screening, diagnosis, and
morbidity/mortality outcomes of HIV-associated cancers and HIV care cascade outcomes among diverse PWH
at UC and NM. The proposed project aligns with the highest impact NIH HIV/AIDS Research priorities. Its
successful accomplishment will solidify collaborations in our interdisciplinary team to support a future R01
application in response to RFA-CA-22-056, “Basic/Translational Research on Health Disparities in
Underrepresented People Living with HIV (PLWH) and Cancer.”

Public health relevance
Project Narrative Clinical and behavioral research studies have shown that the incidence of and mortality due to many HIV-associated malignancies is exacerbated among people with HIV (PWH) compared to HIV negative individuals. Studies investigating how SDoH associate with disparities in the screening, diagnosis, and outcomes of HIV-related malignancies among PWH, however, are largely lacking and urgently needed. Our Chicago-based team will leverage an existing electronic medical records (EMR) data warehouse including PWH from both the Northwestern and University of Chicago health systems that contains recently scaled, high-quality SDoH data capture to fill this key gap in the literature.